Targeting PTGIR-Prostacyclin Signaling to Overcome T Cell Exhaustion and Enhance Anti-Tumor Immunity

PROJECT SUMMARY
Continuous exposure to cancer antigens causes CD8 T cells to become ineffective; a state referred to as CD8
T cell exhaustion (Tex). One hallmark of Tex is the increase in cell surface immune checkpoint proteins that
engage in protein-protein interactions with their respective ligands on cancer cells. Immune checkpoint inhibitors
(ICIs) intercept these interactions and “reinvigorate” Tex cells, and are now a standard treatment for many
cancers. Unfortunately, up to 50% of ICI-treated cancer patients do not respond to treatment or relapse,
indicating that there are other mechanisms that enforce T cell exhaustion. The long-term goal of this project is
to identify and understand these alternative mechanisms, so we can develop complementary therapies that will
deliver more durable clinical responses. To that end, we recently found that hyperactivation of the transcription
factor NRF2 (Nuclear factor erythroid 2-related factor 2) upregulates the prostacyclin receptor (PTGIR) to drive
Tex in mouse CD8 T cells. Specifically, PTGIR signaling reduces the percentage of cytokine-producing CD8+
tumor infiltrating lymphocytes (TILs), resulting in aggressive growth of mouse tumors. Preliminary in vitro data
hint that PTGIR signaling in CD8 T cells may dampen mitochondrial bioenergetics by reducing acetate entry into
the TCA cycle. Conversely, patients (and mice) who have elevated levels of prostacyclin synthase, and hence
prostacyclin, in their tumors exhibit poor overall survival. These data suggest that the PTGIR:prostacyclin
interaction is a novel immune checkpoint that drives mitochondrial dysfunction to enforce Tex. If true, then
pharmacologically intercepting PTGIR-prostacyclin signaling in vivo might be a new means of attenuating T cell
exhaustion and boosting anti-tumor immunity. These hypotheses will be tested in several inter-related Aims using
mouse tumor models. Aim 1 will use a joint RNA-seq/13C metabolomics method to determine how PTGIR drives
T cell exhaustion in vivo, thus linking prostacyclin receptor signaling in the TME to intracellular CD8+ TIL
mitochondrial dysfunction. Aim 2 will leverage 13C metabolomics to show that cancer cells secrete prostacyclin,
and scRNA-seq to show that prostacyclin induces Tex, and an immunosuppressive TME. These data will lay a
foundation for developing prostacyclin synthase inhibitors as an adjunct cancer therapy. Aim 3 will test whether
repurposing of PTGIR inhibitors that block the PTGIR:prostacyclin checkpoint, can prevent Tex, or rejuvenate
an immunosuppressed TME. This project will also help us develop new skills in RNA-seq, scRNA-seq, and in
vivo 13C metabolomics, that will be instrumental in establishing an independent lab and career. Accordingly, our
future team will be in a strong position to develop and test new immune checkpoint inhibitors that target
protein:lipid interactions, which may complement standard-of-care immunotherapies to improve cancer patient
survival rates.

Public health relevance
PROJECT NARRATIVE I recently discovered a protein-lipid immune checkpoint that promotes tumor growth and immune dysfunction. Here, I will determine how cancer cells exploit this checkpoint to evade the host immune system, and demonstrate that blocking this checkpoint can revitalize immune cells to better control cancer.